Effectiveness of Relationship Education for Reducing HIV Incidence in Men Who Have Sex with Men

Men who have sex with men (MSM) are disproportionately impacted by HIV in the United States. Young MSM
(YMSM), particularly YMSM of color, have the highest HIV incidence of any group. Despite the perceived
safety of romantic relationships, main partnerships account for a large proportion of new HIV infections in MSM
(35-68%), and this proportion is much higher amongst YMSM. MSM substantially reduce condom and PrEP
use upon entry into a relationship, despite continued high risk for many couples. However, healthy romantic
relationships provide myriad benefits to individual health and wellbeing. Thus, we created 2GETHER, which
integrates evidence-based relationship education (e.g., communication, conflict resolution) and HIV prevention
(e.g., monogamy/non-monogamy agreements, behavioral/biomedical prevention), to optimize relationship
functioning and reduce HIV risk in male couples. 2GETHER demonstrated evidence of feasibility and
acceptability, as well as preliminary effects on HIV risk behaviors and relationship functioning, in a pilot trial.
We have also adapted 2GETHER for online administration, consisting of 3 online didactic skills modules and 2
videoconference-based skills coaching sessions, and are evaluating its efficacy in a randomized trial. Despite
its promise, we have identified several critical gaps in couple-based HIV prevention: 1) live skills coaching is
burdensome and not cost-effective, 2) many partnered MSM are unable to enroll partners and are thus
excluded, and 3) newer, high risk relationships rarely enroll in trials, so we need to deliver relationship skills to
single MSM before relationship initiation. Our goal is to upgrade 2GETHER into a scalable and tailored
intervention package for both single and partnered MSM, consisting of: 1) a standalone relationship education
and HIV prevention eHealth program (“eRE”) for single and partnered MSM, and 2) two additional dyadic skills
coaching sessions (for MSM participating as dyads only). Aim 1: Evaluate the impact of the tailored 2GETHER
intervention package on HIV incidence in MSM. We will enroll 5,000 HIV-negative MSM to test effectiveness of
the entirety of the 2GETHER tailored intervention package on HIV incidence at 24-months post-intervention
relative to control. We will also explore effects of particular tailored elements: (a) examine differential
effectiveness between single and partnered MSM; (b) among partnered MSM, analyze the additive benefit of
dyadic skills coaching sessions beyond the automated eRE program. Aim 2: Explore differential effects across
treatment arms among subgroups of MSM. We will explore differential effects across treatment arm by age,
race/ethnicity, rurality, and transgender experience. Aim 3: Research the implementation of 2GETHER
nationally to inform scale out and determine cost. Employing a Hybrid Type 1 Effectiveness–Implementation
Trial design, we will use mixed methods to identify facilitators and barriers to implementation. We will measure
key implementation determinants and outcomes through in-depth interviews with national stakeholders to
inform future implementation strategies, and conduct cost analysis to estimate cost of program implementation.

Public health relevance
Project Narrative Men who have sex with men (MSM) are heavily burdened by HIV in the U.S., particularly young MSM and MSM of color, and many new infections occur in the context of primary or main partnerships. The overarching goal of this proposal is to improve public health by establishing the effectiveness the 2GETHER intervention package, an innovative relationship education and HIV prevention program for both single and partnered MSM, in a Hybrid Type I Effectiveness-Implementation Trial design.